MECHANISMS OF ARSINE GAS AND GALLIUM ARSENIDE TOXICITY

Studies have been conducted to evaluate the acute and short-term toxicity of arsine gas. Fisher 344 rats, B6C3F1 and C57BL/6 mice, and Syrian gold hamsters have been exposed to arsine gas at concentrations of from 10 ppb to 50 ppm for periods ranging from .5 hr to 90 days. All groups exposed to a single 6 hr exposure of 25 ppm experienced 100% mortality, while those exposed to 5 ppm for four weeks or 2.5 ppm for 13 weeks showed no overt signs of toxicity. Urine samples from these studies showed increased levels of coproporphyrin and 7 and 8 carboxyl uroporphyrin. These data suggest that alterations in the heme biosynthetic pathway as reflected in increases of specific species of urinary porphyrins may be used as early biological indicators of ongoing arsine toxicity. A method has been developed to improve the measurement of specific porphyrin species in rodent urine to further refine this model. Tissues from these exposures are being analyzed for arsenic content to provide a measure of the tissue dose for specific exposure regimens.